Using artificial intelligence to support efficient same-day diagnostic imaging in breast cancer screening

Breast cancer is the most common solid cancer and the second leading cause of cancer death among U.S.
women. Multiple studies have shown that screening mammography decreases breast cancer-related mortality,
but the implementation of screening has inefficiencies and limitations that contribute to potential harms. False-
positive results and wait times for further evaluation are well-documented mammographic harms. Approximately
10% of all screening exams are recalled for diagnostic workup, of which 95% are found to be false positives,
potentially resulting in benign biopsies and overdiagnosis. The percentage of women recalled for further
diagnostic workup varies between 8-14%, depending on the radiologist. Moreover, the anxiety experienced by a
woman with a recent abnormal mammogram is significant. Many women sleep poorly and struggle to focus as
they await a more definitive diagnostic workup. Given these limitations of screening, our overarching goal is to
minimize practice variabilities associated with recalls, reduce patient anxiety, and increase patient satisfaction.
We propose to assess the feasibility and effect of introducing artificial intelligence (AI) solution at the point of
care to (1) reduce the overall callback rate, (2) increase patient satisfaction by providing immediate screening
results, and for women who require further diagnostic workup, (3) eliminate the delay between screening and
diagnostic workup. The AI solution enables immediate “online” interpretation of screening exams in a high-
volume breast screening program. For women with abnormal mammograms, real-time interpretation of the
screening exam permits women to be scheduled for a diagnostic exam on the same day. This goal is
accomplished in three aims. Aim 1 will validate and integrate an AI algorithm to triage screening mammograms
within our institution’s breast screening population. We will ensure that the algorithm performs at an expected
level (i.e., non-inferior to existing radiologist performance) and integrate and refine the algorithm to communicate
results clearly and efficiently to target users. Aim 2 will design and assess an AI-enabled workflow for same-day
diagnostic exams. We will analyze the current state of care, identify impediments to implementing this program,
and develop changes to the care pathway to allow an AI intervention. In Aim 3, we will implement and evaluate
the impacts of an AI-enabled same-day diagnostic imaging paradigm in three stages: (1) a pilot stage, involving
a subset of women undergoing screening using 2D screening mammography at a single site; (2) an
implementation stage, involving a larger group of women undergoing 2D and 3D screening mammography at a
single imaging center; and (3) an expansion stage, involving women being screened at a second imaging center.
UCLA Health is a unique environment to evaluate this paradigm given the large number of screening exams
performed annually (>40,000 exams) and the distributed nature of its breast screening program across twelve
geographically separated imaging centers. The expected outcome of this project is a generalizable approach for
evaluating and integrating AI algorithms to effect improvements in care delivery.

Public health relevance
PROJECT NARRATIVE Screening mammography has contributed to the 25-40% reduction in breast cancer mortality, but false-positive results and delays in obtaining follow-up imaging are potential harms. We propose an online interpretation, same- day diagnostic imaging paradigm, which aims to eliminate the anxiety-ridden wait times between screening and diagnostic evaluation and reduce unnecessary recalls by using an artificial intelligence solution to triage screen- ing exams. We will study whether implementing an AI algorithm at the point of care can make online reading and same-day diagnostic imaging a reality in high-volume breast screening clinics.